Mechanistic role of P4501 enzymes in the prevention of PAH carcinogenesis by omega 3 fatty acids

PROJECT SUMMARY
The cytochrome P450s (CYPs) are the major enzymes involved in drug metabolism and bioactivation. It is well
known that several CYP enzymes metabolize omega-3 fatty acids to their epoxy metabolites that inhibit
angiogenesis, tumor growth, and metastasis. Numerous polycyclic aromatic hydrocarbons (PAH) are human
carcinogens. PAH-DNA adducts may lead to DNA damage and mutations in critical genes, eventually leading
to cancer. A significant positive linear regression between levels of PAH-DNA adducts and tumor incidence
was observed in animal experiments in our laboratory. We also discovered that omega-3 fatty acids
eicosapentaenoic acid (EPA), docosahexaenoic acid (DHA) inhibited CYP1B1, EZH2, DNMT3a, miR 17,
miR19b-1 and significantly decreased pulmonary and hepatic PAH-DNA adducts, and tumor incidence. The
central hypothesis of this application is that omega 3-fatty acids and their epoxy metabolites will attenuate
pulmonary carcinogenesis by multiple mechanisms entailing attenuation of PAH-DNA adduct formation by
modulating CYPs, as well as by suppression of tumorigenesis, probably via modulation of epigenetic genes
(e.g., EZH2, DNMT3a, miR-17, miR-19b-1). We propose the following Specific Aims. Aim 1: To test the
hypothesis that CYP1A1 and CYP1B1 play mechanistic roles in prevention of PAH carcinogenesis in mice
maintained on EPA, DHA, or EPA + DHA diets, compared to those on a CO diet, followed by exposure of
these mice to BP for the study of the mechanisms. Aim 2: To test the hypothesis that mice deficient in soluble
epoxide hydrolase (sEH) will confer more protection than WT mice to EPA/DHA-mediated prevention of PAH
carcinogenesis, as sEH is known to rapidly hydrolyze epoxy metabolites such as 17,18-epoxy eicosatetraenoic
acid (EEQ) and 19,20-epoxy docosapentaenoic acids (EDP) in serum and tissues to inactive metabolites. In
some experiments, we will treat WT mice with the specific sEH inhibitor, t-TUCB, or a new t-TUCB-like inhibitor
(that is likely to go to human clinical trials soon), followed by treatment of mice with EPA/DHA and BP. Aim 3:
To test the hypothesis that endogenous omega-3 fatty acids, especially their epoxy metabolites, will play a
pivotal role in the prevention of pulmonary carcinogenesis by PAHs in vivo, and that there is a mechanistic link
between CYP1, and sEH. Fat-1-transgenic (Fat-1-Tg) mice, which will convert endogenous omega-6 fatty
acids (rich in CO) into omega-3 fatty acids and decrease the ratios of omega-6/omega-3, will be used in this
study. We will also create Fat-1-Tg/sEH-null mice for exploring the mechanisms by which CYP1 and sEH
enzymes contribute to omega-3 fatty acid-mediated prevention of PAH carcinogenesis. If our hypothesis that
CYP1 and sEH enzymes play important roles in omega-3 fatty acids, i.e. EPA/DHA-mediated prevention of
PAH-induced cancers turns out to be correct, then it will break new grounds in the current understanding of
human cancer prevention. If successful, the proposed studies should lead to novel mechanisms in dietary
interventions against lung cancers induced by PAHs.

Public health relevance
PROJECT NARRATIVE Although omega-3 fatty acids are beneficial in prevention of many diseases including attenuation of cancer risk, the mechanisms by which omega-3 fatty acids attenuate pulmonary carcinogenesis by polycyclic aromatic hydrocarbons (PAHs) are still not fully understood. This project is aimed at elucidating the mechanistic role of CYP1A1, CYP1B1, and soluble epoxide hydrolase (sEH) in omega-3 fatty acids, i.e. EPA/DHA-mediated prevention of PAH carcinogenesis. This proposal is aimed at the development of novel strategies for the prevention of lung cancer induced by PAHs in humans.